Administration and Statistics

PROJECT SUMMARY (See instructions): Shared resource Core A will provide all administrative support to the grant. The core, also provides clinical data management and all statistical support to the research projects and other shared resource cores. Specific areas of administrative responsibility include long and short term planning, review of scientific progress and coordination of the interactions between the shared resource cores and the research projects. Toward these ends, both overall co-Program Directors will participate in this Core. Also, both internal and external scientific advisory committees will be formed to provide independent, expert, program evaluation. Purchasing and personnel management, budget and accounts management, and the preparation and submission of progress reports will also be coordinated by this administrative core. Statistical support provided by this core includes statistical design, control, and analyses of the clinical studies in Projects 1 and 2, and statistical design and analyses of the many different experiments and studies in the other projects and cores.

Public health relevance
RELEVANCE (See instructions): The entire program project effort benefits from the integrated support provided by this core. Administrative and financial organization and supervision are crucial in making possible high quality, productive research, and this core provides this necessary support. Statistical support, trial design, data management and protocol review are essential to the success of the grant's research efforts.